Alveolar organoids and metabolomic-driven cultivation of Pneumocystis species

The proposed studies focus on establishing ex vivo growth systems for the host-obligate fungal genus
Pneumocystis, particularly P. jirovecii and its surrogate model, P. carinii. Pneumocystis species (spp.) infect the
lungs of immune-deficient mammals, including humans, where a life-threatening pneumonia can develop (PjP).
The primary impediment for Pneumocystis spp. research of almost any kind is the absence of a growth system
outside the lungs. These fungi have reduced genomes and lack genes for essential metabolic functions and rely
on their hosts for nutrients. The challenge for successful growth relies on identifying these essential nutrients
and a suitable environmental milieu replicating conditions within the lung alveoli, their microhabitat. Two recent
technologies offer new strategies to address these heretofore unsolved requirements. The assembled team
proposes two approaches for ex vivo growth: a cell-free system guided by metabolomics and establishment of
alveolar organoid cultures. The first approach involves a rational metabolomics strategy to identify essential
nutrients for P. carinii growth. Metabolic Flux Balance Analysis (FBA) will guide the optimal composition and
replenishment schedule for these nutrients providing an iterative process leading to an optimized culture
medium. The second strategy aims to recreate the fungi's specific niche by constructing rat and human alveolar
organoids. Preliminary studies support the feasibility of these innovative approaches, and the assembled team
provides expertise in metabolomics, in vitro culture systems, and organoid construction. The R61 phase specific
aims are to: (1) Conduct metabolite profiling and FBA to identify critical nutrients for P. carinii growth in
a cell-free culture. The surrogate rat model of PjP will provide sufficient organisms for these interrogations, not
possible with clinically obtained samples of P. jirovecii and (2) Develop alveolar organoids using rat-derived
lung cells to support P. carinii's life cycle and growth. Pneumocystis spp. are mostly species specific, and
the alveolar organoids developed from rat lung tissue and infected with P. carinii, are based on this knowledge.
The optimized cell-free medium and the establishment of rat alveolar organoids provide the necessary tools for
transition to the R33 phase, which is to adapt these systems for ex vivo growth of P. jirovecii. These aims include
evaluation of the life cycle kinetics of P. carinii in both systems followed by use of this knowledge to evaluate
these parameters for sustained growth of P. jirovecii in the optimized cell free medium and human alveolar
organoids. This comprehensive plan encompasses metabolomics, FBA, organoid cultures, and detailed
assessments of viability, growth, and life cycle progression for both P. carinii and P. jirovecii, showcasing a
multidisciplinary and innovative approach to understanding and cultivating these fungi. Access of the scientific
community to research tools generated from this work will support new research on Pneumocystis pathogenesis
and virulence and medical treatments against PjP.

Public health relevance
Project narrative. HIV/AIDS remains a significant global public health concern, with 1.5 million new infections and 1 million deaths globally and approximately 39 million people live with HIV/AIDS. Pneumocystis jirovecii pneumonia (PjP) is the most common opportunistic infection in persons with HIV, yet there is no method to grow these pathogenic fungi outside mammalian lungs, impacting almost all areas of research. We propose 2 novel approaches to address this critical need; a metabolomics driven strategy which identify nutrients necessary for continuous growth of these fungi in a cell-free medium; and to recapitulate the microhabitat in the lung where these fungi naturally grow and cause disease by development of alveolar organoids.